Effects of a chromosomal inversion on gene regulation in a major malaria vector

Project Summary: Malaria is a potentially lethal vector-borne disease caused by the Plasmodium parasite and
transmitted by Anopheles mosquitoes. Because malaria continues to be a major threat to global health, newer
and more effective vector control strategies are needed. Anopheles coluzzii mosquitoes are primary vectors of
malaria and segregate for a large, stable chromosomal inversion. This paracentric inversion is associated with
an intrinsic resistance to malaria infection, among other vector competence phenotypes. The mechanism(s) of
how the inversion altered enhancer-mediated gene regulation related to intrinsic malaria resistance are unknown.
Preliminary Micro-C and bulk RNA-sequencing show there are differential chromatin interactions and
differentially expressed genes between alternate inversion forms. I have identified a candidate enhancer (EN1)
that (i) contains the genetic marker to which natural malaria resistance was most significantly mapped and (ii)
contains an inversion-specific single nucleotide polymorphism (SNP) that is responsible for the observed
difference in enhancer activity between the two inversion forms. The central hypothesis is that due to genetic
variation distinctively fixed between alternate inversion forms, EN1 differentially modulates expression
of its target genes in the two inversion forms and underlies the natural malaria resistance phenotype.
Studies in Aim 1 will biochemically characterize the differential interaction(s) of EN1 and its transcription factor(s)
in alternate inversion forms. Electrophoretic mobility shift assays with antibody super-shift will identify the
differentially bound transcription factor. Luciferase assays on cell lines with the transcription factor silenced by
RNA interference will determine if the transcription factor is required for EN1 activity. Studies in Aim 2 will
functionally characterize EN1 by identifying EN1 target genes, elucidating EN1’s role in Plasmodium infection
outcome in mosquitoes, and determining EN1 chromatin interactions under immune stimulation. Collectively,
these data will provide a functional understanding of enhancer-promoter interactions in a medically important
insect vector, especially in the context of a large chromosomal inversion. Findings from this proposal can help
inform the development of better vector control strategies, such as evolutionarily informed genetically modified
mosquitoes, to prevent malaria transmission to humans. Specific training activities planned as part of my
fellowship training include presenting my research yearly at MSTP and departmental Research in Progress
meetings, attending and presenting at national tropical medicine conferences, and presenting my data at weekly
lab meetings. The meetings organized by MCW’s MSTP and the Department of Microbiology and Immunology
allow me to improve my communication skills in sharing scientific data, practice my presentation skills, and
network with experts in the field of vector-borne diseases.

Public health relevance
Project Narrative: Malaria is a potentially lethal vector-borne disease that continues to pose a health risk to approximately half of the world’s population, and Anopheles coluzzii mosquitoes, which are primary vectors of malaria, segregate for a large, stable chromosomal inversion that has been associated with vector competence factors. Mechanisms linking chromosomal inversion form with differential enhancer-mediated gene regulation and expression are not characterized. Therefore, the proposed experiments will biochemically characterize and functionally dissect a candidate enhancer hypothesized to be involved with an inversion-related malaria resistance phenotype, with the goal of informing new vector control strategies, such as the development of evolutionarily informed genetically modified mosquitoes.